Effect of Microenvironment on the Activity of Mycobacteriophages for Treating Mycobacterium abscessus

Novel therapies are needed to control the growing problem of antibiotic-resistant bacterial infections.
Bacteriophages (phages) are viruses that infect and kill bacteria. Because phages and antibiotics differ in their
killing mechanisms, phage therapy is a potential strategy for prevention and treatment of drug resistant
bacteria.
Drug resistant nontuberculous mycobacteria (NTM) infections are on the rise and they are a significant threat
for people with underlying lung diseases such as cystic fibrosis (CF), chronic obstructive pulmonary disease
(COPD) or non-CF bronchiectasis. Mycobacterium abscessus is one of the most common NTMs encountered
in pulmonary NTM disease and it is the most difficult to treat. M. abscessus is extremely drug resistant and
there is no systematically proven regimen that is effective. Phage therapy, involving a cocktail of three
mycobacteriophages (mycophages), was recently employed under compassionate use conditions to treat
disseminated M. abscessus disease in a CF patient. This mycophage treatment was associated with clinical
improvement of the patient. However, the M. abscessus infection of the patient has yet to fully resolve and
twice-daily treatment with intravenous mycophages is ongoing two years later. The limitations of the ongoing
mycophage treatment are unknown.
A significant gap in knowledge for phage therapy is whether phages can interact with their host bacteria in the
different microenvironments encountered during infection. M. abscessus is able to both survive intracellularly in
macrophages and extracellularly in biofilms. Whether mycophages can kill M. abscessus in these
environments is unknown. The ability of mycophages to traverse and act in normal mucus or pathological CF
mucus is also unknown. Working with a collection of M. abscessus isolates and mycophages, including those
from the ongoing clinical case, we will evaluate the impact of each of these potential barriers (macrophages,
biofilms, and mucus) on mycophage activity. The results of these studies will shed light on microenvironments
that may limit phage activity for M. abscessus specifically and, more broadly, inform on potential challenges to
phage therapy for intracellular, biofilm forming, and pulmonary bacterial pathogens. We expect the knowledge
gained will drive development of strategies to improve phage therapy as an option to prevent and treat drug
resistant bacterial infections. Given the need for therapies to treat M. abscessus, this R21 is responsive to
NOT-AI-17-016 (Notice of NIAID’s Interest in Biomedical Research in non-AIDS associated, Pulmonary Non-
Tuberculous Mycobacterial (NTM) Infections).

Public health relevance
NARRATIVE Mycobacterium abscessus is an emerging nontuberculous mycobacteria (NTM) that is notoriously difficult to treat. Treating bacterial infections with phages, which are viruses that infect and kill bacteria, is a promising alternative to conventional antibacterial drugs. Phage therapy was recently used to treat a case of drug- resistant M. abscessus in a cystic fibrosis patient. This proposal will evaluate the ability of phages to act in the different microenvironments in which M. abscessus resides (macrophages, biofilms, and mucus). The knowledge gained from the proposed studies will expand our understanding of the strengths and weaknesses of phage therapy and drive development of strategies to improve phage therapy as an approach for treating M. abscessus infections.